Unified Communications & Audio-Visual Support Services

An interagency agreement between the National Cancer Institute and the Department of Interior Business Center for Unified Communications and Audio-Visual Support Services in support of Projects (1) Audio Visual, and (2) Unified Communications.